2025 Cartilage Biology and Pathology Gordon Research Conference and Gordon Research Seminar

ABSTRACT
Cartilage supports skeletal development from embryos to adulthood. It also serves as an essential skeletal
component of a functional adult skeletal system. Cartilage malformation or degenerative cartilage disease,
most notably osteoarthritis, significantly affects the lifespan, quality of life, and productivity of a large proportion
of the population world-wide. As life expectancy rises, the personal and economic consequences of these
conditions are expected to increase. Since there is an unmet need for treatment and prevention of cartilage
diseases, linking expertise from different research disciplines and career stages is of utmost importance. This
is a request to support the 2025 Gordon Research Conference (GRC) and associated, preceding Gordon
Research Seminar (GRS) on Cartilage Biology and Pathology, which will be held at the Sheraton Fairplex
Hotel & Conference Center, Pomona, California, March 22-28, 2025. The GRC will cover broad basic and
translational research topics with the theme of “Genes, Molecules and Mechanics in Musculoskeletal Tissue
Development and Disease”. The overall goal is to foster collaborations that will ultimately lead to novel
treatments. The 2025 conference is the 11th in the series and owes its success to three major principles. First,
it is the only conference that brings together basic science researchers, clinician-scientists, and biomedical
engineers to cover a broad spectrum of cartilage biology, pathology, and other disciplines relevant to cartilage
research. Second, the program emphasizes unpublished cutting-edge findings, state-of-the-art technologies,
and open discussions. Third, it is open to researchers at all career stages and encourages mentoring,
networking, and collaboration among young, and senior investigators. The 2025 Cartilage GRC will highlight
recent advances and challenges in understanding cartilage biology and disease. The program alternates
between formal presentations, poster sessions and informal discussions. Attendance is limited to 200
participants to promote collegial interactions. Established scientists and talented new investigators will report
and discuss their most recent exciting findings and provide insights into challenges towards understanding
cartilage biology, disease, and therapeutic approaches. Interdisciplinary collaborations are fostered through a
broad base of session topics in an intimate environment, promoting discussion among those in different areas
of research and career stage. For example, bioengineers and clinicians will benefit from learning about how
tissues develop so that those principles can be applied to engineering and regenerative treatment strategies.
The preceding GRS, run by and for trainees, provides a forum for trainees to present and discuss their work
among their peers, building confidence for discussion and networking. In addition, the GRS includes a
mentoring panel, where trainees are provided with information on career paths, grant writing, and other career
topics. We expect the 2025 GRC/GRS on Cartilage Biology and Pathology to empower researchers across
disciplines to make significant progress toward understanding cartilage biology and improving human health.

Public health relevance
Project Narrative Diseases of the cartilage and joints, including osteoarthritis, are a leading cause of disability in the world, disproportionally affecting women and minorities. Osteoarthritis alone affects approximately 7% of the population worldwide and results in significantly reduced quality of life and negative economic impact, affecting gross national product from 1 to 2.5% in countries with market economies, and the impact of these conditions is expected to rise as life expectancy increases. The primary objective of this meeting is to provide a unique venue to present and discuss interdisciplinary research with an emphasis on exposing new investigators to innovations in cartilage and joint development, maintenance and pathology, bioengineering, and translational research, which will have the potential to impact public health in the area of cartilage-related diseases, including osteoarthritis.